INVARIANT PER-GENOME MUTATION RATES

In the late 1960s the then-available data from several laboratories suggested that microbes exhibited a constant forward mutation rate of about 0.003 per genome per replication; genome sizes varied by about 1000-fold, and so, inversely, did mutation rates per base pair per replication. This observation suggested that mutation rates had evolved to an optimum that was surprisingly constant among diverse organisms. Since then, the published data base has improved for many organisms and the invariance of per-genome mutation rates improved appears not only still to be the norm, but to extend all the way from a bacteriophage containing single-stranded DNA to a lower multicellular eukaryote. (The RNA viruses and a DNA plasmid constitute the presently known exceptions.) This data base is being reexamined and analyzed to test the generality of the relationship.